Regulation of Lymphatic Endothelial Cell Junction and Drainage

PROJECT SUMMARY
Lymphatic vessel (LV) differentiation, development, and morphogenesis are central in maintaining fluid
homeostasis, regulating host immunity, and transporting dietary fat and neuronal waste. All these functions
are governed by lymphatic drainage, a transport of interstitial fluid into the lymphatic system through the initial
LVs and collecting LVs. The initial LVs show permeable button-like junction morphology and are ready to
uptake interstitial fluid; by contrast, the collecting LVs are less permeable with zipper-like junction structure,
so that the collecting LVs transport ‘lymph’ to lymph nodes without leaking. Impaired lymphatic drainage
contributes to many human diseases, such as lymphedema, immune dysfunction, fibrosis, obesity, cancer,
and Alzheimer’s disease. While little is known about why LVs become dysfunctional, clinical studies reveal
that inflammation is one of the leading contributors to the lymphatic dysfunction. Although dysfunctional
collecting LVs has been extensively studied, how inflammation impacts initial LV development and
morphogenesis is unclear, because in our current experimental models, including animal models, we often
cannot decouple multifactorial inflammatory factors in the lymphatic endothelium. Since two-dimensional cell
culture has failed to recapitulate three-dimensional (3D) tissue architecture of lymphatics, researchers have
developed 3D in vitro models of LVs, demonstrating lymphatic sprouting, lymphatic network formation, and
LV interactions with other cells. However, these previous models have not created 3D lymphatic structure
with specialized LEC junction development enabling controlled fluid drainage through the button-like
junctions and physiological inflammatory response. In this proposal, we will use a bioengineered in vitro 3D
lymphatic vascular system, exhibiting button-like junction morphogenesis of the LVs and fluid drainage to
understand the regulation of LEC junction and drainage by focusing on ROCK1/2 and integrin α5 signaling.
In Aim 1, we will examine the roles of ROCKs in LEC junction and drainage. Next, we will scrutinize the
mechanisms of ROCKs-mediated junction zippering in LECs. In Aim 2, we will study integrin α5 mediated
regulation of LEC junction and lymphatic drainage. We will then determine signal transduction through
ROCKs and integrin α5 and evaluate therapeutic efficacy of targeting ROCKs and integrin α5 in lymphatic
dysfunction and inflammation models in vivo. In summary, we will use a bioengineered model of 3D lymphatic
vessels and fluid transport to provide an understanding of lymphatic drainage in normal and inflammatory
conditions.

Public health relevance
PROJECT NARRATIVE Lymphatic dysfunction is closely related to major human diseases, including lymphedema, glaucoma, immune dysfunction, cancer, metabolic disease, and neurodegenerative disease. This project will decipher regulation of lymphatic endothelial cell junction and drainage, focusing on ROCK1/2 and integrin α5 signals by using a bioengineered 3D lymphatic vascular system in vitro and mouse inflammation and lymphedema models in vivo.